Laboratory Flexible Funding Model: Enhancing Human Food Testing in North Carolina in Support of an Integrated Food Safety System

Project Summary - Overall
The Food and Drug Protection Division (FDPD) within the North Carolina Department of Agriculture and
Consumer Services will support a nationally integrated and prevention-focused food safety system through
increased surveillance of human foods for microbiological and chemical adulterants and data-sharing with
state and federal partners. The FDPD Laboratory and regulatory Food Program will collaborate to develop and
execute annual sampling and analysis plans aligned with Food and Drug Administration (FDA) priorities.
Because the Food Program has fully implemented the Manufactured Food Regulatory Program Standards and
the Laboratory maintains ISO/IEC 17025 accreditation for a broad suite of microbiological and chemical
analytes, FDPD is confident that all data shared with FDA and partner states will be accurate, precise and
actionable. FDPD additionally commits to responding quickly to emerging threats to the nation’s food supply by
shifting sampling and analysis priorities upon FDA request and assisting FDA with method development
projects that expand food safety testing capabilities.

Public health relevance
Project Narrative - Overall Through targeted surveillance of Food and Drug Administration-prioritized human food commodities for microbiological and chemical adulterants, the Food and Drug Protection Division (FDPD) of the North Carolina Department of Agriculture and Consumer Services will provide state and federal regulatory partners with data to quantify threats to food safety and remove contaminated products from commerce. FDPD will also utilize its ISO/IEC 17025-accredited analyses to support local, state, and federal foodborne outbreak and emergency response activities.